Impact of HLA-II Adaptation on CD4 T-cell and Tfh responses in HIV-1 Vaccination

PROJECT SUMMARY
The purpose of this NIH F30 application is to obtain support for the PI, Jacob Files, for his mentored research
and career development for the next three years. These activities are part of his training requirements that are
necessary for him to obtain his MD/PhD degree, and they will strengthen his potential to become a successful
physician scientist. The major goal of this project is to develop his skills in order to study CD4+ T-cell responses
(CD4 responses) in HIV-1 vaccine recipients using both immunological laboratory assays and computational
techniques. The primary objective of the research proposal is to investigate the impact of HLA-II associated viral
adaptation on CD4 responses in the setting of HIV-1 vaccination. CD4 responses have been found to play an
important role in generating HIV-specific antibodies; therefore, an optimal CD4 response is likely to be an
important component of future preventative HIV-1 vaccines. Our preliminary studies show that current HIV-1
vaccine studies encode a high percentage of HLA-II associated adapted epitopes and that these adapted
epitopes elicit weaker responses in HIV-1 vaccine recipients compared to HLA-II associated non-adapted
epitopes. Therefore, it is possible that a fully HLA-II non-adapted HIV-1 vaccine could lead to a more optimal
CD4 response. This project will investigate the functionality and heterogeneity of the non-adapted and adapted
epitope-specific CD4 responses, with a focus on identifying epitope-specific Tfh cells in HIV-1 vaccine recipients
(Aim 1). Then, the project will determine the contribution of these CD4 responses to the frequency of HIV-specific
antibodies and to B-cell maturation (Aim 2). By characterizing the functionality of the CD4 responses to these
HLA-II associated epitopes and determining their impact on antibody production, our long-term objective is to
inform future HIV-1 vaccine studies of strategies that can improve HIV-specific antibody production, leading to
durable protection from HIV-1 infection.
The proposed training plan for the PI is sponsored by his PhD mentor, Dr. Paul Goepfert. Included in the training
plan are experiences that will help him develop in three major areas: 1) rigorous immunological research in HIV-
1, which includes developing familiarity with the existing literature, critically evaluating published studies, and
training in principles of scientific integrity and responsible conduct of research; 2) competence in bioinformatic
techniques and biostatistical analysis; and 3) career and professional development, including grant writing,
journal article review, clear communication through presentation and manuscript preparation, and translation of
research findings to clinical applications. After completion, this training plan will provide the PI with the foundation
necessary for a successful career as a physician scientist. His ultimate career goal is to one day lead a
translational research team that performs laboratory-based human immunology research to assist in the clinical
prevention and treatment of various infectious diseases.

Public health relevance
PROJECT NARRATIVE In recent years, CD4+ T cells have been found to impact the HIV-specific immune response and assist in the production of HIV-specific antibodies in HIV vaccine recipients; however, further optimization of the vaccine- induced CD4+ T-cell response is needed in order to generate a protective vaccine response. This study proposes to investigate the impact of HLA-II associated viral adaptation of vaccine inserts by comprehensively studying the functionality of adapted and non-adapted vaccine-induced CD4+ T-cell responses with an emphasis on whether these HIV-specific responses exhibit a Tfh phenotype and whether they contribute to antibody production/B-cell maturation. The data collected from this proposal will further our understanding of how HLA-II associated adaptation affects CD4+ T-cell and antibody responses in the setting of HIV vaccination and will inform future HIV vaccine design strategies.